Mechanisms of targeting cellular self-renewal in glioblastoma

ABSTRACT
RNAs are underexploited targets for small molecules or chemical probes of cellular functions. The RNA coding
for overexpressed transcriptional repressors are promising yet invalidated targets for cancer therapy.
Overexpression of B-cell-specific Moloney murine leukemia virus integration site-1 (BMI1), a master polycomb
transcriptional repressor and driver of cellular self-renewal, is a common oncogenic event in many cancers,
including glioblastoma (GBM). We and others have shown that targeting BMI1 could have widely effective anti-
tumor responses. We used cellular and zebrafish reporter screens to identify several molecules that not only
alter BMI1 post-transcriptional processes but also selectively reduce BMI1 protein levels, modulate BMI1 targets
and functionally inhibit cellular self-renewal. Subsequent structure-activity relationship studies revealed the basic
pharmacophore and potential to modulate RNA translation. Upon chemical optimization, we synthesized a set
of novel small molecules, among them are RU-A15 and RU-A16 that target BMI1 and kill tumor stem-like cells
from various cancers at low nM concentrations. We aim to i) establish the mechanism of action of RU-A15 and
RU-A16; ii) study their in vivo effects; and iii) identify BMI1 targets to serve as markers for sensitivity or resistance
to targeted therapy. To achieve this, we generated a set of unique models utilizing normal human astrocytes as
controls, patient derived GBM spheres, organoids and orthotopic patient derived xenografts (PDXs) that more
accurately represent GBM biology than traditional cell lines. We hypothesize that the BMI1 probes selectively
interfere with the post-transcriptional regulation of BMI1 RNA processing, leading to depletion of BMI1 protein
levels and potent anti-GBM activities, including abrogation of cellular self-renewal, inhibition of GBM initiation
and/or growth and sensitization to standard therapy. We will utilize these unique models to reveal the effects of
targeting BMI1 with RU-A15 and RU-A16 and validate these effects in vivo in bioluminescent GBM PDXs and
established genetically engineered mouse model (GEMM) of glioma. In Aim 1, we will utilize physico-chemical
assays to determine the effects of the BMI1 probes on wild-type or mutant RNA using mutate-and-map strategy
and assess the effects of treatment on sphere cell cycle, chromatin binding and key BMI1 targets. In Aim 2, we
will examine the pharmacokinetic, dynamic, potency and selectivity and assess the efficacy of the BMI1 probe
in GBM PDXs vs temozolomide (TMZ) and irradiation (IR). In Aim 3, we will assess the effects of the combined
BMI1 probe with TMZ/IR therapy in orthotopic PDXs and GEMM of glioma. From these advances, we will develop
highly-validated BMI1 probes for RNA targeting and clarify the significance of BMI1 as a therapeutic target both
in GBM and likely many cancers with aberrant BMI1 functions. Our strategy uses a collaborative translational
approach to validate (or refute) future use of the BMI1 probe in clinical applications in large cohorts of patients.

Public health relevance
NARRATIVE BMI1 is amongst the most validated of stem cell-associated proteins, is overexpressed in a wide variety of cancers including glioblastoma, and is shown to contribute to drug-resistance and treatment failure. We plan to characterize the preclinical activity of novel BMI-targeting probes for subsequent clinical studies. We anticipate that these BMI1 inhibitors will have a selective antitumor activity either as monotherapy or in concert with standard-of-care cytotoxic agents and radiotherapy to treat glioblastomas, and feasibly other cancers.